Inducing Mirth to Improve Memory in Depression

Major Depressive Disorder (MDD) impacts an estimated 17.3 million adult Americans per year, which places
an enormous burden on the affected individuals as well as our healthcare system. An understudied but
pernicious component of depression is its harmful impact on people’s ability to remember happy events. If we
gained a clear understanding of neural processes that underly this positive memory deficit, we would be better
equipped to alleviate this disruption. A promising model of this memory deficit posits that encoding of positive
memories is weakened by depression because of dampened dopaminergic (DA) bursts that typically help
encode positive information (Dillon & Pizzagalli, 2018). Furthermore, pleasant events might not effectively
translate into long-term memory storage (and consequently be harder to retrieve) because of their incongruity
with depressed individuals’ dysphoric mood. The goals of the current proposal are to use Event-Related-
Potentials (ERPs) and computational modeling to test and extend this model by determining whether positive
mood induction (via mirth) can alleviate the positive memory deficit in individuals with MDD. The PI will evoke a
P300 ERP in adult participants (96 MDD and 96 Healthy Controls; HCs) during a memory encoding task and
examine whether its amplitude (i.e. strength of neural response) relates to participants’ diagnosis and memory
performance. All subjects will complete a clinical interview on day 1 (Session 1), complete a positive mood
induction (or a control task) and encode 120 pictures day 2 (Session 2). On day 3, following 24-hours to allow
for memory consolidation, participants will complete a memory recognition test (Session 3). P300 ERP will be
triggered in response to positive, negative, and neutral images during memory encoding, by presenting these
pictures at an infrequent (9%) rate intermixed with squares (91% rate). This design will allow us to measure
whether P300 amplitude (which signals DA mediated prediction errors) is lowed in participants with MDD,
relative to HCs, when they encode positive pictures (Aim 1). We will also apply the Hierarchical Drift Diffusion
Model to memory recognition data, in order to test the prediction that adults with MDD will exhibit slower
evidence accumulation (thus, impaired memory reconstruction) as they retrieve positive images, in contrast to
HCs (Aim 2). Finally, we will test the prediction that a mirth induction will raise positive affect, boost P300
responses to positive pictures, and reduce the positive memory deficit in adults with MDD (Aim 3). By
completing this project, the PI will obtain excellent training in applying electroencephalography (EEG),
computational modeling, and mood induction techniques towards translational research. This training will build
on the PI’s expertise in structural neuroimaging and enable him to conduct more clinically impactful research.
McLean Hospital will provide the PI with a world-class environment for conducting this study, with full support
for the PI’s training. Completion of this project and training will ultimately enable the PI to accomplish his goal
of becoming a leader in translational research with a focus on alterations in positive affect.

Public health relevance
Project Narrative Major Depressive Disorder (MDD) is characterized by poor memory for positive events. This positive memory deficit exacerbates the hopelessness that characterizes MDD, and it may be a critical target for treatment—but, unfortunately, the underlying mechanisms are poorly understood. The current project will address this knowledge gap by using electroencephalography (EEG) and computational modeling to study the encoding and retrieval of positive memories in adults with MDD, and by testing whether mirth induction can alleviate the deficit by increasing positive affect and thus restoring neural responses to positive stimuli.